Modeling Aneuploidy-Driven Phenotypes Across Tissues

Abstract
Aneuploidy, the presence of abnormal chromosome numbers, is a prevalent mosaic genetic anomaly observed
at low frequency across all human tissues, with frequency increasing with age. Aneuploidy underlies various
human disorders including most forms of cancer, Down syndrome, and miscarriage/infertility. However,
relatively little is known about the phenotypic consequences of aneuploidy across different chromosomes and
tissues. Over the next five years, our laboratory will address critical knowledge gaps in how aneuploidy alters
gene expression and its downstream effects on cellular phenotypes across chromosomes, cell types, and cell
states using systems-level, quantitative genetic approaches.
Chromosomal copy number alterations (CNAs) impact hundreds or thousands of genes at once,
resulting in complex effects within gene regulatory networks (GRNs). We will examine whether CNAs exert
phenotypic effects in a cell-type-specific manner, using multiplexed CNA fitness quantification approaches
across colon, pancreas, and fallopian tube epithelial cells. These assays will systematically evaluate the fitness
impacts of CNAs across the genome, enabling identification of cell-type-specific aneuploidy fitness profiles.
This project will leverage human telomerase-immortalized diploid cell models to establish a comprehensive
collection of non-lethal aneuploid cell lines from each tissue type, enabling deep investigation into how
aneuploidy influences cellular fitness.
Additionally, the Watson Lab seeks to better model transcriptomic and phenotypic output of CNAs,
since many of the gene expression changes in aneuploid cells affect non-CNA-resident genes. By integrating
transcriptomic data with transcription factor regulatory networks, this study will reconstruct tissue-specific GRN
models to predict the downstream effects of CNA-driven multigene dosage alterations. These models will be
used to explore how CNA-driven signals propagate through regulatory networks, revealing new insights into
how CNAs disrupt GRNs to support tumor growth in the case of cancer-enriched CNAs, and, conversely, how
GRNs may fail in cases of growth-inhibiting or non-viable CNAs. These studies will thus enhance our
understanding of GRN robustness in response to polygenic perturbations. Genome-wide CRISPR screens will
be performed to identify essential genes in the context of aneuploidy, with a focus on uncovering synthetic
lethal interactions that could be leveraged for aneuploidy-targeting therapies. This comprehensive, systems-
level approach will provide unprecedented insights into the mechanisms through which aneuploidy affects
gene expression, cellular phenotypes, and disease progression across different tissues.

Public health relevance
Project Narrative The project focuses on understanding how aneuploidy, the phenomenon of having an abnormal number of chromosomes, affects gene expression and cellular phenotypes across different tissues. Using systems-level genetic approaches and multiplexed assays, we will investigate how chromosomal copy number alterations impact cell-type-specific fitness in colon, pancreas, and fallopian tube epithelial cells. Integration of transcriptomic data with gene regulatory network models, along with comprehensive aneuploidy synthetic- lethality mapping across tissues, will reveal new insights into aneuploidy-driven phenotypes and potential therapeutic targets for aneuploidy-driven diseases.